Mechanical regulation of transcription in dental epithelial stem cells through cell packing and tissue forces

Project Summary
Effective utilization of somatic stem cells to repair injured tissues or to bioengineer organs is an important goal
in regenerative medicine. However, clinically-proven application of stem cells in therapies remains limited in
medicine today. The translational hurdles are in large part due to our lack of ability to precisely control stem cell
proliferation and differentiation, which is critical for safe and effective clinical use. To overcome this challenge,
we must first deepen our knowledge of normal stem cell regulation in organs. In addition to biochemical signals,
tissue mechanical forces exerted by cell pulling and pushing can in theory serve as a signaling mechanism to
regulate gene expression and various cellular processes in adult stem cells. However, the modulation and
influence of these force signals within a 3D tissue are dramatically understudied, leaving open questions around
how stem cells sense and interpret forces. We and others have demonstrated the mouse incisor as a powerful
model system to study adult epithelial stem cells and we have previously shown that the transcription co-factor
Yes-associated protein (YAP) and chromatin repression are important for regulating incisor epithelial stem cells.
Our initial studies indicate that both mechanical deformation of cells and the cell geometry associated with dense
packing can influence the expression of YAP and repressive chromatin marks in the incisor stem cell niche. The
mouse incisor thus provides a valuable in vivo platform to study how cellular organizations coordinate mechanical
signals to control stem cell functions via YAP and chromatin. In this application, we propose to test the hypothesis
that dense cell packing modulates the effect of tissue forces on nuclear deformations, which in turn regulate YAP
nuclear entry and H3K27me3-mediated transcriptional repression in the dental epithelial stem cells. To test this:
Aim 1 will characterize the force patterns, magnitude, and nuclear stiffness in wild type incisors, specifically in
the densely packed dental epithelial stem cells and the more loosely packed transit amplifying cells.
Aim 2 will study how changes in the cell geometry and packing affect tissue force patterns, nuclear deformations,
YAP localization, and chromatin states. We will perform mechanical rescue experiments to test the role of forces.
Aim 3 will address the functional role of lamin A in regulating nuclear stiffness and heterochromatin formation in
the dental epithelial stem cells, as well as its scaling response to cell packing.
Together, these studies will deliver a mechanistic understanding of how tissue forces control dental stem cells
and yield findings that will be of general interest to both dental researchers and to the stem cell and regenerative
medicine communities.

Public health relevance
Project Narrative As human teeth have limited regenerative potential, tooth loss is a common and chronic condition that can deeply affect our lifestyles. The continuously growing mouse incisor offers an ideal system to study dental stem cells and a thorough understanding of the molecular process that regulates tooth stem cells is crucial to efforts to develop stem cell-based therapies for regenerating human teeth. We propose to investigate the role of tissue architecture and forces during dental epithelial renewal in mice and the proposed study will be transformative because it will for the first time reveal how these physical factors are coordinated to control gene expression in epithelial stem cells.